Promoting Well-Being Across Adulthood: The Role of Conflict Avoidance

TBD

Public health relevance
RELEVANCE This project is relevant for public health because negative relations and chronic stress are associated with health problems including cardiovascular disease, diabetes, and depression. Thus, identifying the most beneficial coping strategies will help to improve the health and well-being of adults as they age.